Facilitating the Implementation of Population-wide Genomic Screening (FOCUS)

Population-wide genomic screening (PGS) for Hereditary Breast and Ovarian Cancer Syndrome, Lynch Syndrome, and Familial Hypercholesterolemia offers great promise in identifying the 1-2% of the population that unknowingly carries a pathogenic variant that puts them at elevated risk for serious, yet preventable disease. Rapidly decreasing sequencing costs, endorsement of PGS by national bodies, and attention to precision medicine applications have rapidly accelerated the spread of PGS programs. To date, no clear guidelines or implementation strategies exist to support the rapid growth of PGS. Contextual factors, including program-level procedures, organizational structure, and characteristics of the patient population, influence implementation of these large-scale PGS initiatives. To help facilitate growth of PGS programs and enhance recruitment and retention of representative populations into genomic initiatives, we propose to identify best practices for PGS implementation and develop and test a freely available, online multicomponent implementation guide (FOCUS toolkit). This project will establish a gold standard approach for integrating PGS and offer the field generalizable methods and knowledge about PGS implementation. Specifically, using a stakeholder-engaged Implementation Mapping approach we will: 1) conduct a qualitative needs assessment among ten PGS programs (FOCUS design sites) at various implementation stages (emerging, implementing, sustaining) guided by the Consolidated Framework for Implementation Research, 2) develop and produce the FOCUS toolkit consisting of implementation strategies, materials, and protocols, and 3) evaluate the impact of the FOCUS toolkit on Reach, Effectiveness, Implementation, Adoption, Maintenance outcomes for PGS in 12 PGS sites (FOCUS test sites) using a stepped wedge cluster randomized trial design. All aspects of this project will be conducted by an exceptional investigative team and supported by a ten-person Implementation Mapping Advisory Panel consisting of representatives from public health and regulatory agencies, communities and patient groups, and clinical stakeholders. These findings will: 1) provide a standardized approach and evaluation framework for programs seeking to strategically implement and expand population-based approaches for identifying individuals and families at high risk of serious, yet preventable disease, 2) provide generalizable methods and knowledge about PGS, and 3) support efforts to bring the promise of precision health to all.

Public health relevance
Population-wide genomic screening (PGS) for Hereditary Breast and Ovarian Cancer Syndrome, Lynch Syndrome, and Familial Hypercholesterolemia offers the best chance of identifying the nearly two million people in the US who have these conditions and need tailored disease prevention and clinical management. This project will use an Implementation Mapping approach to conduct a needs assessment of ten PGS programs (Aim 1), develop and produce a multicomponent implementation guide (FOCUS toolkit) to facilitate the implementation of PGS programs (Aim 2), and evaluate the FOCUS toolkit using a hybrid stepped wedge cluster randomized trial among 12 sites at various stages of implementing PGS (Aim 3). These findings will provide a standardized approach for programs seeking to strategically implement PGS and support efforts to bring the promise of precision health to all.